Statistical and agent-based modeling of complex microbial systems: a means for understanding enteric disease transmission among children in urban neighborhoods of Kenya

Climate change models predict an increasing frequency of droughts, extreme rainfall, and floods globally,
which will increase global morbidity and mortality from infectious diarrheal diseases. Urban, high-poverty
neighborhoods in low-income countries (LICs) that lack wastewater infrastructure may experience the worst
impacts of climate-driven diarrhea outbreaks. Slums and informal settlements experience frequent and pro-
longed seasonal flooding each year that overflows drains, open defecation sites, and septage pits, spreading
fecal waste with diarrheal pathogens across communities. Climate change is poised to increase the frequency
and severity of these floods, and the number of people in a population vulnerable to waterborne disease in LIC
cities. The science of predicting flood location, severity, and duration in urban landscapes is still limited, in part
because these floods are driven more by manmade landscape modification and small bodies of water, rather
than meteorological systems associated with large lakes, rivers, and oceans. Additionally, urban landscapes
are extraordinarily heterogeneous in extent and quality of infrastructure development, green space, and popu-
lation density. Multiple slums and middle-class neighborhoods with very different levels of vulnerability to flood-
ing may be interwoven within one small 10 kilometer squared space, suggesting aggregated measures like
daily municipal precipitation may not be consistent indicators of floodwater exposure across urban communi-
ties. The effectiveness of diarrheal disease transmission models, like the PATHOME Study (TW011795) in
Kenya, in recommending disease prevention interventions would be improved if models accounted for variance
in floodwater exposure risk at small spatial scales. Multiple satellites now in orbit around the earth generate
fine-resolution spatial climate data that can be analyzed by open source hydrometeorological models to map
flood events at small scales. The goal of this supplemental proposal is to generate neighborhood-specific indi-
cators of precipitation and flood hazards during one year of time in a slum and middle-class neighborhood in
Nairobi, Kenya participating in the parent PATHOME Study. We aim to generate localized estimates of precipi-
tation and the occurrence, intensity, and duration of flooding in our study neighborhoods, using web-based
open source flood modeling platforms and fine-resolution (<1 kilometer) satellite data. Then we will test
whether precipitation and flooding differs between neighborhoods. These data will be integrated into our
broader datasets for modeling the role of flood events on observed enteric pathogen transmission dynamics in
each neighborhood. We hypothesize that satellite data will reveal differences in frequency of exposure to flood-
ing between urban neighborhoods. This supplement will be implemented by the PATHOME PIs and an expert
in climate and urban flood hydrometeorological modeling, and will contribute to the training of an international
graduate student from a LIC. Broader impacts of this study include demonstrating new uses for earth data to
investigate climate-driven infectious disease in urban LIC settings.

Public health relevance
This administrative supplement research will impact global public health by using fine-resolution satellite data and open source hydrometeorological flood modeling platforms to demonstrate that extreme precipitation and flood inundation events vary between an urban slum and middle- class neighborhood in Nairobi, Kenya. This neighborhood-level microclimate data will improve the capacity of our parent study to accurately model climate events as a cause of exposure to waterborne enteric pathogens in urban neighborhoods with different levels of infrastructural development.